Clinical Sciences Core

Project Summary/Abstract (Clinical Sciences Core)
The CFAR Clinical Sciences Core (Core C) provides unique clinical resources and scientific leadership for the
largest network of HIV investigators in South Florida and promotes high impact HIV translational and
multidisciplinary human subjects research through partnerships with clinical, socio-behavioral, and basic
scientists. Under the leadership of Dr. Maria Alcaide (Core Director) and Dr. Charlie Mitchell (Co-Director), in
collaboration with the Biostatistical Sub-Core, Core C has supported over 70 investigators, 124 studies, and
almost 200 publications over the past 4 years. Core C has significantly contributed to the success of junior
investigators, including those from underrepresented groups and women. The success of Core C is strengthened
by strong institutional support for HIV research (one of the pillars of the University of Miami strategic plan for
research), and by facilitating the access to institutional programs not commonly supporting HIV research. The
specific aims for Core C are: Aim 1) To provide state-of-the-art facilities for implementing clinical and translational
studies, including support for rigorous clinical assessments, biological sample collection, and access to well-
characterized high-quality data. Core C supports fully equipped and staffed research static and mobile units, and
the development of CFAR databases; Aim 2) To provide research design methodology and technical assistance
to meet regulatory standards in research involving human subjects, human data, and biological specimens, and
to facilitate training/education of investigators in clinical research. Research methodology needed in key areas
will be provided by the highly qualified and experienced Core C investigators and staff, and training will be
accomplished by facilitating the use of institutional resources not commonly used by HIV investigators; and Aim
3) To provide biostatistical support throughout the project lifecycle, through the CFAR Biostatistics Sub-Core.
Core C biostatisticians will collaborate in planning study design for pilot studies, formulate statistical approaches
consistent with study aims, guide the development of data collection tools using electronic data entry systems,
support statistical analysis and interpretation, and participate in the development of manuscripts and grant
submissions. Without support from Core C research units, highly qualified clinical staff, robust databases and
biostatistical support; Miami CFAR investigators would not be able to conduct high impact multidisciplinary
research that will slow the progression of the epidemic in South Florida, and ultimately, end the HIV epidemic in
the US.